Identifying the role of the gut microbiome in the etiology of benign breast disease

PROJECT SUMMARY/ABSTRACT
The overall goal of this project is to identify the role of the gut microbiome in the etiology of benign breast disease
(BBD), and thereby shed light on its pathogenesis in relation to breast cancer. Approximately one out of every
five women in the United States has been diagnosed with BBD, a well-established risk indicator for breast cancer.
BBD share the hormonal-related risk factors with breast cancer. However, the underlying mechanisms linking
hormone factors and breast disease are not clear. Emerging evidence suggests that the gut microbiome may be
significantly involved in breast disease through the influence on systemic estrogen homeostasis. This evidence
supports the hypothesis that the gut microbiome is a key player in breast disease, and it may mediate the
associations between hormonal risk factors and BBD. However, no study has systematically studied the role of
the gut microbiome and its metabolome on BBD. Dr. Wang proposes to be the first to test this important
hypothesis. She will leverage the sub-studies embedded in the well-characterized Nurses’ Health Study II, to
test the three specific aims. In Aim 1 (K99), she will identify potential differences in gut microbial composition
and functional variation by various hormonal factors among ~1800 participants. In Aim 2 (R00), she will
characterize the associations between gut microbiome composition and the high-risk, proliferative subtype of
BBD in a nested case-control study (N=300) with breast biopsy sample collection. In Aim 3 (R00), she will
incorporate the functional readout of gut microbiome, the fecal metabolomics, to estimate the associations
between microbial metabolomic signatures and BBD in the same nested case-control study. Innovative shotgun
metagenomic sequencing and semi-targeted metabolomics will be used to discover microbial strains and their
metabolites. By integrating metagenomics and metabolomics, she will comprehensively investigate taxonomic
composition and functional potential of gut microbial communities that are directly involved in BBD, as well as
the potential mediating role of the gut microbiome underlying the hormonal factors-BBD associations. Results
from the proposed study may pave the way for novel personalized BBD and breast cancer prevention for high-
risk women defined by their hormonal profiles, with the potential modulation of gut microbiome. Dr. Wang’s
research aims are supported by a well-rounded training plan tailored to her two training goals: 1) Obtain training
and apply advanced bioinformatic analytics to large microbiome metagenomic and metabolomics datasets; and
2) Develop advanced knowledge on hormonal determinants on BBD epidemiology, etiology, pathology, and
pathogenesis as it relates to breast cancer. The training environment at Brigham and Women’s Hospital fosters
productivity and collaboration with world class biomedical scientists, and she have assembled a multidisciplinary
mentoring team that includes leading experts in BBD, human microbiome, bioinformatics, hormonal factors,
breast pathology, and breast cancer epidemiology. This K99/R00 award will help her gain the knowledge and
experience necessary to effectively pursue her career as an independent breast cancer investigator.

Public health relevance
PROJECT NARRATIVE This proposed project aims to identify specific compositional and functional features of gut microbiome that are directly involved in benign breast disease (BBD), and reveal the possible role of gut microbiome in mediating the hormonal risk factors-BBD risk association. This project will identify novel gut microbial and metabolomic markers that can advance future risk prediction of BBD, inform more effective microbiome-based interventions aimed at BBD risk reduction among high-risk women defined by their hormonal profiles, which ultimately will help reducing the growing burden of BBD and breast cancer-associated morbidity and mortality.